Novel drug delivery strategies for treatment of breast cancer brain metastases

With an increasing number of women serving in the military, there is a significant need to effectively manage our
active duty and Veteran women who develop breast cancer. In the United States alone, ~276,000 women will
be diagnosed with breast cancer, of whom ~42,000 are predicted to die from this disease this year. Patients
diagnosed with triple negative breast cancer (TNBC) and human epidermal growth factor receptor 2 (HER2)-
positive breast cancer have an increased likelihood of distant recurrence in the brain compared to other breast
cancer subtypes – exceeding 35% of metastatic breast cancer patients. Brain metastases (BMs) confer dismal
prognosis, as existing treatments have very limited efficacy; indeed, median survival for TNBC patients after
detection of metastatic disease is ~5 months. Multiple unique barriers limit effective drug delivery to breast cancer
BMs. These barriers include (i) the blood-brain barrier (BBB) within the normal brain parenchyma and the blood-
tumor barrier (BTB) within metastatic lesions; (ii) elevated tumor interstitial pressure and the dense
electrostatically charged brain extracellular spaces (ECS) which together limit convective and diffusive drug
penetration; (iii) the activity of multidrug resistance (MDR) pumps expressed by both brain capillary endothelial
cells and tumor cells, which reduce drug levels within tumor cells; and (iv) the brain glialymphatic system (GLS),
which acts as an efficient drug clearance system. Thus, new therapeutic delivery strategies designed to mitigate
and surmount these barriers will likely offer new promise towards effectively treating BMs.
Accordingly, we propose to couple an emerging therapeutic delivery technology, decreased nonspecific
adhesivity, receptor-targeted nanoparticles (DART NPs) with MRI-guided focused ultrasound (MRgFUS) for
treatment of breast cancer BMs (BCBMs). DART NPs will be engineered to target Fn14, a member of the TNF
receptor superfamily that is highly expressed in primary breast cancer and breast cancer BMs; but minimally in
normal breast, brain, or other organs. Research findings from our team related to the development and
application of DART NPs and MRgFUS-enhanced drug delivery that motivate the proposed studies include: (1)
DART NPs rapidly penetrate in brain and breast tumor tissues ex vivo, selectively targeting Fn14-positive tumor
cells both in vitro and in vivo, and significantly enhancing drug retention within intracranial tumors in vivo. (2)
MRgFUS-induced BBB disruption (BBBD) can safely increase DART nanoparticle delivery into the normal brain
parenchyma. (3) Fn14-targeted DART NPs containing the chemotherapeutic paclitaxel (PTX-DART NPs) are
more effective than free PTX in killing cancer cells that overexpress the MDR1 efflux pump. (4) PTX-DART NPs
more effectively reduce tumor growth and improve animal survival in mammary fat pad and intracranial TNBC
xenograft models compared to Abraxane, an FDA-approved nanotherapeutic currently used to treat breast
cancer patients. The proposed work will build on these findings to test the hypothesis that clinical-grade PTX-
DART NPs in combination with MRgFUS-induced BBBD will provide superior delivery, drug retention, and
therapeutic efficacy in BCBMs compared to the clinical standard drug treatments. The results from this study
also have the potential to make an impact on both male and female military service personnel with other Fn14+
cancer types that frequently metastasize to the brain; specifically, lung cancer and melanoma.

Public health relevance
With an increasing number of women serving in the military, there is a significant need to effectively manage active duty and Veteran breast cancer patients. Despite progress in early cancer screening and improving systemic therapies; the percentage of breast cancer patients developing brain metastasis is increasing - particularly those diagnosed with the human epidermal growth factor receptor 2 (HER2)-positive or triple-negative breast cancer (TNBC) subtype. Breast cancer patients harboring brain metastases face a dismal prognosis; indeed, in the case of TNBC patients, median survival after detection of metastatic disease can be as short as 5 months. Thus, there is an urgent need to identify new therapeutic targets for breast tumor cells residing in the brain microenvironment and develop innovative drug delivery strategies for effective killing of these cells without harming nearby normal brain neurons and glial cells.